Network on Life Course Health Dynamics and Disparities in 21st Century America

Project Summary/Abstract
Most measures of adult health and longevity in the United States lag well behind those of other wealthy countries.
Despite widening recognition of this crisis, we have only a limited understanding of its causes and few strategies
to reverse them. This proposal, a renewal of the highly successful Network on Life Course Health Dynamics and
Disparities in 21st Century America (NLCHDD) funded for the past five years by the National Institute on Aging,
lays out a plan to further develop the scientific groundwork, human capital, and data and analytic infrastructure
to answer critical questions about the U.S. health and longevity crisis. Our overarching objective over the next
five years is to strengthen and focus the NLCHDD to generate new evidence and disseminate data and analytic
resources to better understand the trends and disparities in U.S. adult health and longevity across the life course
and in geographic context. We will do so through four specific aims. First, we will direct attention and resources
toward four targeted scientific questions that will shed light on the multi-layered determinants of the troubling
trends and growing disparities in U.S. adult health and longevity. These questions (described in detail in the
proposal) focus on how state and local contexts—separately and collectively—shape trends and disparities in
adult health and longevity across the life course. Second, we will strategically grow the interdisciplinary Network
of emerging, established, and underrepresented scientists who will collaborate to investigate the key scientific
questions. Third, we will provide development and training opportunities for Network scientists via pilot grants,
grant proposal mentoring, working groups, and annual meetings. Fourth, we will develop and disseminate data
and analytic resources to foster innovative research on the key scientific questions and advance science in this
critical area. Our Network is innovative in its focus on the multi-layered contextual determinants of trends and
disparities in adult health and longevity across the life course; in its openness and evolving nature; in its efforts
to incorporate emerging investigators with more established ones; and in its central concern for support,
mentoring, and development of emerging and underrepresented scholars. This emphasis on human capital
development is reflected in all aspects of the Network's organization and operation. Our Network is also unique
in its attention to focusing on research that can inform policies and interventions and provide the foundation for
future research advances. Finally, our Network is unique in that it will facilitate the expansion, integration, and
public dissemination of new and existing databases on population health determinants at state and local
contexts. The renewal Network brings together a PI team and four sites that span the U.S. with substantial
experience in developing large-scale population health research and complementary scientific strengths
connected to the Network’s aims. Using its complementary strengths, developmental maturity, and geographic
diversity, the NLCHDD leadership and overall Network is poised to make important scientific inroads over the
next five years on the U.S. population health and longevity crisis.

Public health relevance
PROJECT NARRATIVE Most measures of U.S. adult health and longevity lag well behind those of other wealthy countries, particularly for U.S. women, middle-aged adults, and areas in the South and Midwest. Explaining this growing U.S. disadvantage necessitates large-scale, coordinated research and data development activities across disciplines. This Network will bring together scientists across disciplines to collectively investigate the U.S. crisis, provide training for Network scientists, and disseminate resources and research to inform decision-makers and improve the health and longevity of the aging population.